Brain networks for specific motor control impairments following stroke

PROJECT SUMMARY / ABSTRACT
The objective of the parent grant (R01 HD094731) is to determine if combining TheraBracelet with hand task
practice is superior to hand task practice alone for recovery of hand function post-stroke in an adequately
powered study. The parent grant Aim 2 focuses on determining the effect of TheraBracelet on sensorimotor grip
control and neural communication within the cortical sensorimotor network. This diversity supplement will provide
a new insight into the neural mechanisms for different grip control impairments among individual stroke survivors.
Specifically, the aim of this diversity supplement is to determine the brain network responsible for the feedforward
and feedback motor control in stroke survivors. It is hypothesized that feedforward motor control will be
associated with connectivity within the motor cortices during the motor planning phase, while feedback motor
control will be associated with connectivity between the sensory and motor regions during the motor execution
phase. This research is expected to unveil the specific brain network responsible for the feedforward and
feedback motor control of the upper extremity. Innovation is in investigating brain networks and motor controls
together. This new knowledge will be critical for the development of a personalized post-stroke rehabilitation
paradigm: This paradigm may involve first assessing individual motor control processes to determine the specific
motor control that is responsible for clinical motor impairment, followed by design of a personalized treatment to
target the specific brain network responsible for the impaired motor control. Most importantly, this award will
foster the underrepresented minority candidate (Mr. Adam Baker) as a career DPT/PhD researcher. The training
activities will focus on developing new research skills for Mr. Baker to perform the supplement research and
begin his research career. Specifically, Mr. Baker will (1) enhance the overall knowledge of the
neurorehabilitation research field, (2) acquire proficiency in quantifying, analyzing, and interpreting feedforward
and feedback motor control biomechanics data and EEG-based brain network data, and (3) develop a successful
application for a DPT/PhD program. Therefore, this supplement award will contribute to enhancing diversity in
the biomedical workforce, as only 2,000 females are American Indian or Alaskan Native out of 1.76 million
employed scientists and engineers holding doctorates according to NSF report (data suppressed for males due
to reliability).

Public health relevance
PROJECT NARRATIVE The proposed diversity supplement aims to reveal the neural mechanisms responsible for impaired hand grip control post-stroke. Thus, the supplement informs the new insights of post-stroke hand grip control and underlying neural mechanisms that can guide precision rehabilitation treatment, ultimately contributing to improved rehabilitation outcomes for stroke survivors. This supplement also will foster development of the underrepresented minority candidate toward a clinician-researcher career in rehabilitation research and to enhance diversity in the biomedical workforce.